Center for Undiagnosed Diseases at Stanford Administrative Supplement

ABSTRACT
Although gene panels and exome and genome sequencing (GS) have enabled molecular diagnosis for many
rare disease patients, a significantly large proportion of these patients remain undiagnosed. A combination of
clinical expertise, advanced genomic and multi-omic technologies and efficient computational tools is needed
for higher diagnostic yield. Lack of insurance or denial of test reimbursement by insurance further negatively
impacts rare disease patients from underprivileged and economically weak backgrounds, making it critical to
improve the outreach and diversity in rare disease study cohorts. The Center for Undiagnosed Diseases (CUD)
at Stanford will continue our efforts toward sustainability, refinement of methods, and integration with regular
clinical practice. Here, we propose a program of study that will (1) facilitate accurate diagnosis of patients with
undiagnosed diseases, with emphasis on those without or with limited insurance or economical or language
barriers; (2) use novel approaches in data analysis and integration of different ‘omes to improve diagnostic
rates; and (3) enhance our understanding of the impact of diversity on the diagnostic process. In Aim 1, we
propose to triage and enroll patients, complete clinical evaluations and associated work. This will include pre-
visit chart review and genetic counseling followed by an individualized visit during which standardized
phenotypic and environmental data are collected. Biosamples facilitate genomic, multi-omic, and cellular
evaluation of disease. We will apply novel computational approaches for systematic integration of genomic,
transcriptomic, metabolomic, and phenotypic data with the entire medical literature to improve diagnostic yield.
We will continue our efforts to seek diagnosis using available resources for all participants. In Aim 2, we will
focus on increasing participant diversity, engagement, and advocacy. This will be accomplished by expanding
our local patient advocacy partnerships, including a local UDN PEER group. We aim to increase applications
from underrepresented and underinsured patients through regional outreach to safety net hospital systems and
providers. Further, our streamlined evaluations will increase access to underserved participants. Finally, we will
prioritize onboarding multilingual staff to enhance participant experience.

Public health relevance
NARRATIVE The Center for Undiagnosed Diseases at Stanford, a member site of the Undiagnosed Diseases Network, will continue to diagnose the undiagnosed while transitioning to a new model of sustainability. Our Center will continue to bring Stanford’s technology development, genomic data analysis, stem cell biology, and translational science to the team-based diagnosis and care of patients with undiagnosed disease. We will continue to optimize the diagnostic process and integrate care of the undiagnosed into clinical practice while preserving the scientific mission of the Undiagnosed Diseases Network.